NExT FdCyd_THU NSC112907 (CT029-402-448-003), TO#3 Milestone 2 - THU bulk drug analysis, DTP-18-026, HHSN261201700014I, Analysis of Anti-Cancer Chemical & Pharmaceutical Formulations PRB

The analysis of bulk drug lots to be used in clinical trial, according to FDA regulations.